Health Literacy and Health Disparities Among the Elderly

DESCRIPTION (provided by applicant): This career development award proposes a program of training, data collection and research to advance knowledge in the area of health literacy and health disparities among the elderly. Specifically, the aims of this project are (1) to understand the relationship between measures health literacy and more general measures of cognition, such as memory and numeracy; (2) to estimate the relationship between health literacy, general cognition and health outcomes in a large and nationally-representative sample of older Americans; (3) to analyze the mechanisms through which health literacy and cognition affect health outcomes; (4) to analyze the role that health literacy plays in determining health disparities across racial, ethnic or socio-economic groups; (5) to explore similarities and differences between the concepts of health literacy and financial literacy, and compare the relationship between literacy and outcomes in both domains. The research activities will be carried out through a program of primary data collection and secondary data analysis based on the Health and Retirement Study (HRS). The primary data collection consists of a module of questions on health literacy and health knowledge to be collected from a subset of respondents to the 2010 wave of the HRS. Analysis of the data will also be carried out with guidance from an interdisciplinary team of mentors.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study examines how an individual's health literacy - that is, the ability to understand and process information related to health - affects his or her health. The study focuses on how health literacy in the elderly and near-elderly population is related to more general cognitive skills such as memory and the ability to do simple math problems. The study will provide information to help improve the health of older Americans. Project Narrative This study examines how an individual's health literacy - that is, the ability to understand and process information related to health - affects his or her health. The study focuses on how health literacy in the elderly and near-elderly population is related to more general cognitive skills such as memory and the ability to do simple math problems. The study will provide information to help improve the health of older Americans. __SpecificAimsTextDelimiter__ 10. Specific Aims As modern medicine becomes increasingly complex and patient-driven, and as the burden of disease shifts toward chronic conditions requiring patient self-management, the cognitive burden placed on elderly individuals to manage their own health and medical care will only increase. Insurance programs, too, increasingly require beneficiaries to make active decisions about their own coverage; for example, the typical enrollee in Medicare Part D must choose from a menu of dozens of plans with different premiums, deductibles, cost-sharing, and coverage provisions. Some people are better equipped than others to face these complex tasks. The notion of "health literacy" - the ability to understand and process information necessary to make good decisions about health - is, increasingly, the focus of attention from researchers and policymakers.1 There is a growing body of research showing that health literacy is an important predictor of health outcomes; I review this literature in detail below. A number of studies have also explored the possibility that health literacy may be one key to understanding racial and socioeconomic disparities in health outcomes that have, so far, defied explanation. From a public policy perspective, understanding the relationship between health literacy and racial disparities is particularly appealing because of the possibility that targeted interventions to improve health literacy might yield a "double dividend" of improving health outcomes and reducing racial and socioeconomic status (SES) disparities. The literature to date on health literacy suffers from three shortcomings. First, there has been very little attention to the fact that the most widely used measures of health literacy may in fact be measuring general cognitive ability, rather than distinguishing among health-specific cognition, health-specific knowledge, and general cognition, although these distinctions are critical to designing interventions to reduce disparities. Second, in spite of the obvious parallels between health literacy and financial literacy, no research to date has linked these two emerging literatures and exploited the similarities between the cognitive tasks facing the elderly in the areas of health and personal finance in order to gain insight into how decision-making might be improved. Third, most studies have relied on small and unrepresentative samples, such as patients at a single clinic or enrollees in a particular Medicare Advantage plan. I propose a period of training and research that will allow me to address these shortcomings and significantly advance the literature on health literacy and disparities. The specific aims of the proposed work are the following: 1. To refine the measurement of health literacy and health knowledge in a large-scale survey of the elderly. 2. To estimate the relationships between health literacy, general cognition and health knowledge. 3. To estimate the effect of cognitive ability on health and insurance outcomes among older individuals and to identify mechanisms through which this effect operates. 4. To determine whether differences in cognitive ability can explain persistent disparities in health outcomes across racial and socioeconomic groups. I plan to achieve these aims through data collection and research activities during the five years of the training period. These projects are facilitated by the training activities described in Section 4 above, which include (1) formal coursework in cognitive aging and psychology of aging with Jacqui Smith, Ph.D., a psychologist; (2) directed reading in the area of cognition and measurement under the guidance of Jacqui Smith and Jack McArdle, Ph.D.; (3) mentoring from Robert Willis, Ph.D., an economist, on all aspects of the proposed research and on career development more generally; (4) guidance from Dr. McArdle and from David Weir, Ph.D., PI of the HRS, and Mick Couper, Ph.D., on the design of survey instruments to measure health literacy and health knowledge; and (5) collaboration with Kenneth Langa, MD, Ph.D., one of the co-PIs of the HRS and an expert in the measurement of cognition among the elderly. 1 Healthy People 2010 defines health literacy as "the degree to which individuals have the capacity to obtain, process, and understand basic health information and services needed to make appropriate health decisions." The data collection activity, mentioned above and discussed in more detail below, involves developing measures to be administered to subsets of respondents in the 2010 and 2014 waves of HRS to test health knowledge and health literacy. These data will be used for some of the studies listed below. The research studies that I plan to carry out in order to achieve the specific aims of the award are as follows: Study 1: Measuring health literacy: general or specific skills? (with Ken Langa) Study 2: Financial literacy and health literacy: A review Study 3: Navigating Part D: How does cognition matter? Study 4: Cognition and health behaviors: Disparities by race and SES Study 5: What predicts mortality? The importance of general cognition, health literacy and health knowledge (with Ken Langa) These studies, which are described in more detail in Section 13 below, provide a foundation for my independent research agenda aimed at understanding how cognition and health literacy shape disparities in insurance and health outcomes among the elderly.